Immunological bases of the beneficial effects of exercise on skeletal muscle aging

PROJECT SUMMARY
An increase in human life expectancy without a proportional extension of time spent in good health, or
“healthspan,” has led to expansion of the global population of aged and frail individuals with multiple morbidities.
Chronic exercise improves healthspan in multiple model organisms, and physical activity level is inversely
associated with all-cause mortality risk in humans. There is a preponderance of evidence for the benefits of
physical activity and exercise in youth and during aging, yet the cellular and molecular mechanisms underpinning
these benefits remain ill-defined. Previously, I demonstrated that appropriate inflammatory tone in muscles is
required for normal tissue- and organism-level metabolic adaptations and improved performance in response to
exercise. The current research plan will advance our understanding of exercise-induced immunomodulation and
its effects on muscle physiology and age-related muscular decline. My preliminary data show that muscle stromal
cells potentiate exercise-induced muscle inflammation in response to mechanical stress; this is exacerbated in
aged muscles. In Aim 1, I will test the hypothesis that an appropriate level of mechanical-stress-mediated stromal
activation is critical for the immunological, metabolic, and functional adaptations to exercise observed in young
mice; in aged mice, excessive mechanical stress augments muscle inflammation, which limits these adaptations.
In Aim 2, I will determine the contributions of muscle stromal cells and macrophages to the opposing effects of
inflammation, in particular IFN, and exercise training on age-related decline in muscle function. I postulate that
aging skews muscle stromal-cell and macrophage phenotypes toward states that contribute to muscular decline
and that training is sufficient to counter these changes. Furthermore, I hypothesize that increased IFN signaling
into stromal cells and macrophages is a basis of age-related decline in muscle function. In addition to conceptual
advancements, the present proposal will generate rich transcriptomics datasets and multiple mouse strains of
utility in my future independent studies. I have completed most of the Aim 1 experiments involving young mice
and will continue Aim 1 in both the approval and award phases. The approval phase will be completed at Harvard
Medical School in the joint-lab of Drs. Diane Mathis and Christophe Benoist, leaders in immunological tolerance
and systems immunology. In the approval phase, I will work with my advisory committee to polish my skills in
mentorship, grant writing, communication, and lab management. This training will be complemented with formal
instruction in the form of courses and workshops designed to promote professional development and
independence. I have an unwavering passion for immunometabolism, and I have structured my scientific training
to afford me with a diverse skillset suitable for establishing a productive niche in which I can lead a successful
laboratory. The datasets generated by this plan, in particular the transcriptomic and metabolic profiles of muscle-
resident cells from the proposed experimental conditions, will inform my laboratory’s future work aimed toward
understanding metabolic regulation of skeletal muscle inflammation and adaptation during exercise and aging.

Public health relevance
PROJECT NARRATIVE Skeletal muscle mass, strength, and endurance capacity decline with age, contributing to loss of mobility and increased frailty in late life. Physical activity and exercise (intentional physical activity) are long-known means of maintaining muscle function during aging and extending the portion of one’s life spent in good health, or “healthspan;” yet, the mechanisms responsible for the benefits of exercise are not completely understood. As a follow-up to my previous work demonstrating the importance of muscle inflammatory tone in the regulation of mitochondrial metabolism and endurance capacity, the proposed project will deepen our understanding of how muscle-resident cells sense and respond to exercise; how aging alters the profiles of these cells; and how exercise in mid or late life reprograms muscle-resident cells to enhance muscle function and improve healthspan.